Novel DWI Methods to Minimize Postoperative Deficits in Pediatric Epilepsy Surgery.

Project Summary/Abstract
For the millions of epilepsy patients with drug-resistant seizures, surgical resection of epileptogenic brain tissue
is often the only remaining therapeutic option. Especially in young patients who do not obtain seizure control or
suffer from unacceptable side effects from medications, there are further concerns about the effect of seizures
on development: even brief but repetitive seizures cause cognitive regression and detrimental psychosocial
effects. This motivates a particular urgency to investigate a more structured, quantitative, and non-invasive tool,
which is capable of informing families and providers to decide timely surgery by accurately providing the
probabilities of both favorable and unfavorable postoperative outcomes using data from preoperative imaging
analysis at the whole-brain level. The overall goal of this project is to develop a novel tool of benefit-risk analysis
for the presurgical evaluation of pediatric drug-resistant focal epilepsy. Toward this goal, we will validate a state-
of-the-art deep learning-based diffusion MRI technique to provide the resection margin (i.e., the distance
between epileptogenic area and eloquent area) resulting in maximized benefits (i.e., seizure freedom and long-
term neurocognitive improvement) and minimized risk (i.e., deficits in eloquent functions including
motor/language/hearing/vision). With NIH support, we have established diffusion-weighted imaging maximum a
posteriori probability (DWI-MAP) analysis with Kalman filter, which can provide individual patients with the
optimal resection margin, yielding successful avoidance of motor/language/visual deficits in 93%/91%/90% of
patients with ≥75% of patients benefiting from seizure freedom. Recently, we have also found that deep
convolutional neural network (DCNN) can provide an excellent accuracy (94-100%) to classify true positive tracts
of eloquent brain areas, suggesting that DCNN-based tract classification may outperform the DWI-MAP in
detecting diverse function-specific white matter pathways. Aim 1 of this project will investigate if a combination
of DCNN-based tract classification with Kalman filter even better predicts the resection margin, resulting in
seizure freedom and avoidance of functional deficits at a large cohort. Aim 2 will investigate if an advanced DWI
approach integrating DCNN and DWI connectome helps decide timely surgery by providing 1) preoperative
imaging markers underlying high likelihood of postoperative neurocognitive improvements and 2) mechanistic
insight in structural brain reorganization associated with postoperative verbal IQ improvement. The results of this
project are expected to ultimately improve clinical management of pediatric epilepsy by translating deep learning-
based diffusion MRI technique to optimize the surgical margin, predict the postoperative neurocognitive outcome,
and determine specific mechanism of postoperative brain reorganization, which will be validated for optimizing
clinical benefit-risk analysis before surgical intervention.

Public health relevance
Project Narrative In this renewal application, we will investigate a novel tool of benefit-risk analysis for the presurgical evaluation of pediatric drug-resistant focal epilepsy which utilizes the state-of-the-art deep convolutional neural network (DCNN)-based tract classification to provide an optimal resection boundary of the epileptogenic area resulting in the maximized benefit (seizure freedom) and minimized risk (functional deficit including motor, language, hearing, and vision). We will also study if the integration of DCNN and DWI connectome helps decide timely surgery by providing preoperative imaging markers underlying a high likelihood of postoperative neurocognitive improvements and mechanistic insight in structural brain reorganization associated with postoperative verbal IQ improvement. The results of this project will translate deep learning-based diffusion MRI techniques to optimize the surgical margin, predict the postoperative neurocognitive outcome, and determine the specific mechanism of postoperative brain reorganization, which will be validated for optimizing clinical benefit-risk analysis before surgical intervention.